Translating Autoantibodies Into Chimeric Antigen Receptor-T cell Therapy for Small Cell Lung Cancer

Abstract
For the last 30 years, the 5-year survival rate of small cell lung cancer (SCLC) has been less than 7% despite
the addition of immune checkpoint inhibitors as treatment options. Therapies like immune checkpoint inhibitors
that aim to reengage an immune response may not succeed for SCLC as previous studies have shown
downregulation of MHC molecules, low PD-L1 expression and limited immune infiltration. However, SCLC is
often associated with autoantibody-driven Paraneoplastic Syndromes, providing evidence for the
immunogenicity of SCLC. We propose that chimeric antigen receptor T cells (CAR-Ts) as a novel approach for
SCLC immunotherapy that overcomes impediments to endogenous immunity. CAR-Ts are synthetically
engineered to fuse antibody ligand binding domains with costimulatory components that activate T cells after
engagement of cell surface antigens, and have had considerable success in leukemia, lymphoma, and multiple
myeloma. The microenvironment of SCLC is phenotypically closer to CAR-T responsive lymphoma than many
solid tumors where CAR-Ts have thus far had limited success. A challenge for CAR-T cells in many solid tumors
is the identification of target antigens that are tumor-specific. We have identified 13 novel cell surface antigen
and here will prioritize 3 with high prevalence in SCLC. Each of these antigens have post-translational
modifications that act as neoantigens and lead to autoantibody production in a high percentage of SCLC cases.
We will capture these neoantigen-autoantibodies from SCLC patient-derived B cells, sequence the tumor specific
binding sequences, and design and test CARs constructed from the single chain variable fragments (scFvs).
The benefit of isolating autoantibodies from SCLC patients to detect tumor-specific neoantigens is three-fold: 1.
The antigens identified have already proven to be immunogenic; 2. The variable regions of these human
autoantibodies can be directly engineered into ligand binding domains of CAR-T cells; and 3. Autoantibodies
can be detected in the blood of patients and serve as tissue surrogate biomarkers to guide CAR-T cell target
selection. The CAR-T cells we develop will be rigorously tested in multiple preclinical models that address
complementary but non-overlapping therapeutic barriers. These include testing CAR-T cell tumor infiltration,
efficacy and toxicity in a library of genetically diverse SCLC patient derived xenografts and identifying, then
overcoming, immunosuppressive mechanisms in the immune competent Rb/p53 genetically engineered mouse
model. Our team of experts in lung cancer, autoantibody biomarkers, immunology and CAR-T cells is well
equipped to execute the development of novel immunotherapies that are desperately needed in SCLC.

Public health relevance
Project Narrative Small cell lung cancer (SCLC) is a highly aggressive, recalcitrant and deadly cancer with no effective treatment. We have found that SCLC leads to production of neoantigens and autoantibodies, the binding sequence of which can be engineered into chimeric antigen receptor T cells (CAR-Ts) that could provide a badly needed new avenue for SCLC treatment.